Improving Functioning among Aging Women Veterans

Anticipated Impact on Veteran’s Healthcare: The VA’s commitment to serving all Veterans must include
effective, gender-informed services that address the needs of women Veterans. This application will address
this need by exploring one method of offering gender-informed care by tailoring an existing intervention to
optimize functioning among mid-life and older women Veterans.
Background: Women are the fastest-growing cohort of Veterans. They have higher rates of age-related health
concerns than non-Veteran women, experiences that are further complicated by intersecting mental, physical,
and gender-linked stressors. One prominent example of this intersection is menopause, a health transition
period that can be associated with negative health impacts and functional challenges. [These difficulties can be
further complicated for women Veterans given high rates of physical and mental health conditions as well as
exposure to challenging experiences associated with military service (e.g., military sexual trauma, service-
connected conditions, combat exposure).] The VA urgently needs interventions that integrate such knowledge
to help VA healthcare providers effectively, respectfully, and efficiently address the needs of aging women
Veterans via gender-informed, tailored approaches. Cognitive behavioral therapies for menopause (CBT-
Meno) are promising treatments for disruptive menopause concerns, showing effectiveness among non-
Veteran women for many menopause symptoms (i.e., sleep, hot flashes, anxiety, depression), and quality of
life. However, CBT-Meno research has not addressed the needs and risk factors specific to women Veterans
and is limited in assessing functional outcomes. Research and VA policy also highlight the need for gender-
informed interventions to address women Veterans’ health concerns, including menopause care.
Project Objectives: This proposed CDA-2 research study will address these clinical and research gaps by
testing one approach for delivering gender-informed services to aging women Veterans by: (1) integrating
stakeholder feedback to tailor Cognitive Behavioral Therapy for Menopause (CBT-Meno) for women Veterans
with menopause concerns; and (2) refining and evaluating tailored CBT-Meno as a treatment to address the
intersecting needs of women Veterans with menopause concerns. This application will first, develop a tailored
version of CBT-Meno, to be delivered via telehealth, utilizing feedback from stakeholder panels to address the
intersecting care needs of women Veterans with menopause concerns. Second, it will examine the initial
acceptability of tailored CBT-Meno through a pre-pilot group with women Veterans with menopause concerns –
seeking feedback from the women Veteran participants and the stakeholder panels to inform refinement of
tailored CBT-Meno for testing in Aim 3. [Third, a single-arm pilot trial of tailored CBT-Meno will be conducted to
examine the feasibility, acceptability and fidelity of tailored CBT-Meno, and its impact on women Veterans'
functioning, quality of life, and menopause symptom severity among women Veterans ≥45 years with
menopause concerns.]
Project Methods: The tailoring of CBT-Meno will start with existing knowledge and incorporate input from
stakeholder panels of women Veterans, VA providers, and women Veterans’ healthcare leaders to create a
first draft of tailored CBT-Meno, which will be used to examine its acceptability in a pre-pilot group with women
Veterans aged ≥45 with menopause concerns (N=6). Next, findings will be integrated with additional
stakeholder feedback to generate a finalized version of tailored CBT-Meno for testing in Aim 3. [Then, tailored
CBT-Meno will be tested in a single-arm pilot trial (N=48) enrolling the same population.] Feasibility,
acceptability, fidelity, and preliminary efficacy will be assessed via quantitative and qualitative methods. The
trial will assess health, quality of life, and community functioning at Baseline, Post, and Follow-up timepoints.

Public health relevance
Women are the fastest-growing group of U.S. Veterans. Over half of those using VA care are 45 or older, with more age-related health concerns than civilian women. The VA urgently needs gender-informed strategies to ensure women Veterans receive tailored care that addresses their intersecting mental, physical, and age- related health concerns, as well as gender-linked stressors. One prominent example is menopause, a health transition period that, for many women, can be associated with negative physical and mental health concerns that can worsen their functioning and quality of life. This project will: [(1) integrate stakeholder feedback to tailor Cognitive Behavioral Therapy for Menopause (CBT-Meno) for women Veterans with menopause concerns; and (2) refine and evaluate tailored CBT-Meno as a treatment to address these intersecting needs.]